Molecular mechanisms reprogramming transcription in quiescent cells

The long-term goal of the proposed research is to characterize the molecular mechanism(s) by which cells
are reprogrammed into quiescence. This reprogramming is essential for cells to maintain viability over
long periods of time without divisions, such as quiescent stem cells and memory lymphocytes. On the
other hand, this reprogramming also allows early-disseminated cancer cells to evade treatment by
maintaining their state of quiescence. Therefore, deciphering the mechanisms and factors involved in
cellular quiescence is both a fundamental biological question and informative in health and disease.
We are approaching this in a systematic manner by focusing on a model organism, the fission yeast S.
pombe. This model has a ‘minimal set’ of genes allowing viable long-term quiescence, and retained
epigenetic mechanisms such as histone marks and RNA interference, which are essential in non-dividing
cells. By identifying this minimal set and using high-throughput approaches available in fission yeast, our
goal is to understand the basic principles and key components of reprogramming in quiescence, without
the confounding effects due to the added complexity of multicellular organisms, where differentiation and
intercellular communication occur and affect quiescence.
Among several pathways that we have found to be essential for quiescence maintenance, we are
focusing specifically on two complementary factors, which are not only conserved across eukaryotes, but
also most likely to impact our understanding of reprogramming: in aim 1, we will study how a core
component of the Mediator complex is essential specifically in quiescent cells to maintain basal
transcriptional activity; in aim 2, we will focus on ERH, a small enigmatic protein, which acts as a
repressor of transcription in quiescence. We will employ a combination of genetic, genomic, biochemistry
and bioinformatics approaches to understand how these two complementary regulators shape gene
expression in quiescent cells. Because both Mediator and ERH are mis-expressed in cancers with strong
metastatic potential, we expect our results to shed some light not only on transcriptional reprogramming in
physiological quiescent cells, but also on how this process is mis-regulated in tumor dormancy.